THE PRIMARY OBJECTIVE OF THE PROPOSED PHASE I WORK IS TO FURTHER DEVELOP A PROOF-OF-CONCEPT (POC) MACHINE LEARNING APPROACH TO DETECT ILLEGAL OPIOID SELLERS AND DEVELOP IT INTO AN MVP THAT CAN COLLEC

NIH through NIDA solicits the research and development of data-driven solutions and services that focus on issues related to opioid use prevention, opioid use, opioid overdose prevention or OUD treatment (PHS 2019-1, NIH/NIDA Topic 166)